Investigating how mechanical connectivity yields developmental robustness

ABSTRACT
It is essential for the fate of an organism that key morphogenetic processes occur reproducibly even
under tissue damage or environmental perturbations. While much is known about how genetic redundancy and
regulation achieves robust development, less is understood about how a tissue mechanically ensures
reproducible shape change when perturbed. This project uncovers how populations of physically interacting
cells mechanically respond to challenging conditions and modify their collective behavior to still sculpt the
correct final shape.
One way for cells to coordinate tissue-scale forces and movements is through direct mechanical
connections. In fact, many developing tissues exhibit supracellular networks of actomyosin connections that
link hundreds of cells. A large roadblock has been with the challenges of imaging and quantifying subcellular
protein at the tissue scale. I adapted a topological smoothing algorithm originally used to trace high-noise
filamentous structure of galaxies in the Universe to data to trace high-noise filamentous myosin structure in
confocal images. This allowed for the first quantification of a supracellular myosin network across an entire
tissue over developmental time. Subsequent analysis adopting techniques from network theory allowed me to
identify that the robust folding of the Drosophila fruit fly embryo during ventral furrow formation is mechanically
ensured by patterns in the supracellular network spanning its ventral cells.
This newly discovered importance of supracellular networks in coordinating robust shape change
highlights the need for a comprehensive understanding of how supracellular networks form, and how their
patterns impact the function and robustness of a population of cells. Deciphering robustness at the tissue-level,
where the displacement and fate of hundreds of cells must be considered, requires techniques at the interface
of cell and developmental biology, biophysics and computer science. The proposed project will take a highly
interdisciplinary approach to identify how supracellular network patterns are controlled molecularly, at the cell
level, and via tissue constraints. As well, how heterogeneity in tissue-level patterns impacts morphogenetic
robustness will be addressed. Together this comprehensive study of the structure and function of supracellular
networks will represent a new way to interpret mechanical robustness across diverse developing tissues. As
well, a generalized description of mechanical robustness has the potential to uncover new paths to predict and
control tissue malformation, which would represent a significant advance for both developmental biology and
fetal medicine.

Public health relevance
PROJECT NARRATIVE The robust establishment of correct shape is essential for proper tissue function. Tissue shape change is a mechanical process that necessitates the coordinated force generation and motion of thousands of cells. Identifying how physically interacting cells mechanically respond to challenging conditions and modify their behavior to still sculpt the correct final shape will shed light onto many congenital disorders that result from morphogenetic dysregulation.